Anatomy and Physiology of Molecular Layer Heterotopia

PROJECT SUMMARY ABSTRACT
Neocortical malformations due to defective neuronal migration are often associated with epilepsy and life-long
cognitive impairment. Therefore, understanding the anatomical and physiological changes accompanying
neocortical malformations are important for the development and design of novel treatments for affected
individuals. Molecular layer heterotopia (MLH) are neuronal migration defects characterized by collections of
misplaced neurons in layer I and are observed in numerous neurodevelopmental disorders including: dyslexia,
epilepsy, cobblestone lissencephaly, Fukuyama muscular dystrophy, and GPR56 polymicrogyria. Surprisingly,
little is known about the cellular mechanisms and physiological changes associated with MLH despite the variety
of disorders and clinical presentations associated with heterotopia. Studies in mice with identical MLH to those
observed in humans offer the potential to develop a greater understanding of MLH. Thus, the proposed studies
will use Gpr56 knockout mice with MLH to describe the neuronal and glial changes that accompany heterotopia
using spatial transcriptomics and quantitative microscopy techniques. In vivo calcium imaging in Gpr56 knockout
mice crossed to calcium-indicator mice will be used to test the hypothesis that heterotopia result in hyper-
excitable neuronal circuitry changes that underlie seizures and cognitive deficits. Finally, the proposed work will
provide exciting research opportunities that will train undergraduate and osteopathic medical students in
developmental neuroscience to prepare them for possible graduate studies or future careers in biomedical
science.

Public health relevance
PROJECT NARRATIVE: A number of human neurodevelopmental disorders are associated with molecular layer heterotopia such as dyslexia, epilepsy, cobblestone lissencephaly, Fukuyama muscular dystrophy, and GPR56 polymicrogyria. How heterotopia cause seizures and cognitive disability in these conditions has been largely understudied. Greater understanding of the changes in neuroanatomy and physiology that are associated with heterotopia in mouse models, may provide new avenues for the development of therapies for patients.